Monitoring CAR T Cell Therapeutic Response and Toxicity with Real-time, Label-free Cell Quantification

Chimeric antigen receptor (CAR) T cell therapy has emerged as a transformative immunotherapy for cancer,
autoimmune diseases, and transplantation. In this treatment, a patient’s immune cells are isolated and
engineered to express a synthetic CAR on their surface to direct T cell reactivity towards diseased cells.
Patient CAR T cell quantity throughout the therapeutic process is a contributing indicator of the efficacy of
immune response as well as an immediate sign of toxicity through complications such as cytokine release
syndrome and immune effector cell-associated neurotoxicity syndrome. However, current methods for
quantification are costly in both time and money, precluding point-of-care clinical support. There is a critical
need for real-time, low-cost CAR T cell quantification.
We propose a rapid, label-free, and cost-effective technique for CAR T cell counting in patient blood
using surface enhanced Raman spectroscopy (SERS) and machine learning (ML). Aim 1 entails optimizing a
SERS approach to collect Raman spectra from immune cells. This includes the development of methods in
Raman spectroscopy and sample preparation, and plasmonic gold nanorod fabrication and surface
modification. In Aim 2 we will develop and optimize ML infrastructure to classify and quantify engineered T cell
spectra from that of other cells. Finally, in Aim 3 we will digitize patient blood samples mixed with nanorods into
single T cell droplets, from which we extract optical signals for each cell using Raman spectroscopy and use
ML to quantify CAR T cells. By conducting this procedure on patient blood over the course of CAR treatment,
we will generate efficient cell quantification data that can be correlated to therapeutic impact with significant
time and financial advantage over previous methods.
Our proposal combines innovations in cancer biology, immunology, nanophotonics, and machine
learning to develop a technique that will benefit researchers, clinicians, and patients for safer, more effective
CAR-therapies. The successful completion of this project will lead to further efficient label-free methodologies,
for example in cell receptor expression level quantification, strengthening the addition of this technique to the
immunologist’s toolbox. Both the specific aims of this project as well as its future potential strongly align with
the agency’s mission. This research will allow for the advancement of fundamental knowledge of CAR T cells
and the downstream impacts of CAR expression on immune cells. Additionally, its application in patient care
has the critical potential to benefit CAR therapy development and minimize fatal complications, aiding in
enhancing health and reducing illness.

Public health relevance
This project aims to develop a rapid, label-free, and cost-effective method for patient blood Chimeric Antigen Receptor (CAR) T cell quantification combining surface enhanced Raman spectroscopy and machine learning. The application of this method in the unmet need for point-of-care CAR T cell counting will provide input on therapeutic efficacy and critically indicate signs of toxicity to overall improve patient outcomes for this treatment. In both the short and long term, the proposed research promises to provide new insights into CAR T cell mechanisms as well as to enhance the development of safer and more effective CAR therapies.